CSHL 2025 Mechanisms of Metabolic Signaling Conference

Cold Spring Harbor Laboratory Conference on
Mechanisms of Metabolic Signaling
May 13-17, 2025
Project Summary
This proposal seeks support for the meeting on “Mechanisms of Metabolic Signaling” to be
held at Cold Spring Harbor Laboratory in May 13 - 17, 2025. The meeting will assemble leaders
in the field, together with junior faculty, postdoctoral fellows and graduate students, to discuss the
latest advances in our understanding of metabolic regulation and its role in normal physiology as
well as a variety of disease states ranging from obesity to cancer.
Metabolic processes are required for life, and are remarkably similar from organism to organism
and from cell to cell. In mammals, specific cell types use metabolic pathways in highly specialized
ways to conduct their cell-specific functions. Further, the specialized function of some cell types
serves to maintain metabolic homeostasis of the multicellular organism by regulating levels of
hormone and metabolite messengers in the bloodstream. Metabolic diseases such as obesity
and diabetes result when those processes fail. At the same time, cancer is increasingly
recognized as a state whereby the malignant cell proliferates by altering its fuel metabolism and
ignoring metabolic signals.
The meeting will cover a broad spectrum of topics ranging from Metabolic Crosstalk with Genome
and Epigenome to Interorgan Crosstalk and Nutrient Utilization. In addition, one session is
dedicated to Emerging Technologies in the field. Each session will be chaired by a leading
scientist in the field. Oral presentations will be given by a group of distinguished invited speakers
as well as speakers selected from submitted abstracts. Selected speakers will include graduate
students, postdoctoral fellows and junior faculty aiming for maximal inclusion of young
investigators. Of special importance are the two poster sessions, where many participants can
present their work in an atmosphere conducive to informal discussion. The meeting will be of
moderate size, and we expect about 250 people to attend, the vast majority of whom will be
presenting a poster or talk. Session chairs and presenters will be required to attend in-person to
ensure a critical mass of attendees gathering at Cold Spring Harbor; however, we will facilitate an
additional virtual audience layered on top of the in-person attendance. We took this approach
successfully at the 2023 meeting. This will be important because virtual attendance at meetings
will help to reduce the effects of scientific conferences on climate change and enable more
equitable participation from labs around the world.

Public health relevance
Mechanisms of Metabolic Signaling LAY NARRATIVE Metabolic pathways are largely the same from cell to cell, yet cell-specific fluxes through these pathways govern cell-specific functions. Deviation from the norm, due to environmental or genetic changes, can lead to organismal metabolic imbalance as in obesity and diabetes, or to cell-autonomous imbalance as in cancer. A great challenge is to understand the control of metabolic physiology, and how this is perturbed in a disease-specific manner. To stimulate innovation and cross-disciplinary interactions related to metabolism, we propose to convene a group of outstanding basic and clinical researchers studying metabolic regulation of physiology and disease in a variety of systems, in a meeting entitled "Mechanisms of Metabolic Signaling" at Cold Spring Harbor Laboratory in May, 2025.